Data-driven Modeling and Ultrasound-based Control of Afferent Nerve Stimulation for Tremor Suppression

PROJECT SUMMARY
Over 11 million people in the United States are affected by unintentional and uncontrollable rhythmic movements
due to parkinsonian tremor, essential tremor, and cerebellar tremor. Individuals experiencing tremors in the hands
and arms face difficulty performing activities of daily living. Electrical stimulation that works by stimulating motor
nerves of antagonistic muscles is a potential wearable option for tremor suppression when medication is ineffective,
but prior to pursuit of effective yet invasive (and costly) brain surgery. However, the two significant drawbacks of
motor nerve stimulation are stimulation-induced muscle fatigue and discomfort due to high stimulation intensity. An
intriguing new method of stimulation targets afferent nerve fibers to inhibit tremor in antagonistic muscles. These
fibers relay sensory information on muscle position and velocity back to the spinal cord. By stimulating these fibers,
spinal neural circuitry can be modulated that in turn inhibits muscle activity due to the descending tremor inputs
from the brain. The new method uses low stimulation intensity, which is comfortable and fatigue resistant. However,
modulating its stimulation parameters to continually disrupt tremors remains challenging, largely due to the
numerous interactions that can occur between stimulated afferent nerves and the descending tremorgenic neural
inputs. These interactions occur through a complex neural circuitry whose modeling is difficult and computationally
intensive for determining stimulation parameters in real-time. Direct measurements of muscle velocity and length
changes with ultrasound can help create a data-driven model of afferent stimulation and help design individual-
specific afferent stimulation parameters. However, ultrasound has never been used for tremor suppression control.
Real-time algorithms and models that map ultrasound-derived muscle activity to oscillating limb displacement are
yet unestablished. These algorithms and models are needed to automate individual-specific stimulation parameters
for tremor suppression. Lastly, for future clinical translation wearable ultrasound arrays that monitor multiple
muscles need to be developed. The following two specific aims will address this work. SA 1: To model afferent
feedback during tremor activity and design and validate a model-informed afferent stimulation strategy.
SA2: To develop a wearable ultrasound array. If successful, a data-driven model of afferent stimulation will
automate an individualized tremor suppression intervention. A future clinical translation of data-driven modeling,
afferent stimulation technology, along with the wearable ultrasound array will improve the quality of life by assisting
in suppressing prominent distal tremors.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Tremors that are involuntary oscillations of muscles in the hands and arms are caused by neurological disorders such as Essential Tremor, Parkinson’s disease, and cerebellar ataxia. A tremor makes activities of daily living challenging and can cause an increased reliance on care providers. The research objective is to suppress tremor activity in muscles by using an ultrasound-based characterization of the tremoring muscles and stimulation of afferent nerves.